Statistical methods for breast cancer survival using the restricted mean survival time

Summary
Breast cancer is a complex and heterogeneous disease where the roles of many prognostic factors, including
androgen receptor (AR) which is an emerging potential prognostic biomarker, remain unclear in its clinical pro-
gression. The Nurses' Health Studies (NHS), which motivated this application, are large prospective cohort
studies conducted to investigate the risk factors for major chronic diseases in women including breast cancer.
The data from the NHS contain invaluable information for breast cancer research such as lifestyle, hormonal,
and genetic risk factors, as well as clinical outcomes such as breast cancer diagnosis, recurrence, and death. In
many epidemiologic studies on breast cancer survival, including the NHS, the hazard ratio (HR), which is esti-
mated based on the proportional hazards (PH) model, has been the most routinely used effect measure despite
its limitations. In the NHS data, the PH assumption in the association between AR expression and breast cancer
survival was found to be violated. The interpretation of HR is challenging and the result is often misleading if the
PH assumption is violated, which makes it difﬁcult to assess AR's prognostic values. Recently, summary metrics
based on the restricted mean survival time (RMST), which is deﬁned as the life expectancy up to a speciﬁc time
point, have attracted substantial attention as useful alternatives to the HR. The RMST has many advantageous
features such as its straightforward interpretation and robustness. Speciﬁcally, we can assess the prognostic
factor's effects in terms of absolute effect, which is clinically more interpretable than the HR, without assuming
PH using the RMST-based regression model. In this project, we propose to develop novel statistical methods
based on RMST to fully utilize the rich data from the NHS and to gain a better understanding of the complex
effect of AR on breast cancer progression and survival. Under Aim 1, we will develop a ﬂexible regression
method based on RMST that estimates the varying covariate effects across a range of time. The proposed
regression method will be used to elucidate the clinical signiﬁcance of AR in survival by different subtypes of
breast cancers. Under Aim 2, we will develop a model-free approach to summarize the bivariate survival
data (i.e., time from an initial event to an intermediate event and from the intermediate event to a failure
event). The metrics developed under Aim 2 will be used to study residual survival after breast cancer recurrence
and facilitate comparisons between groups by AR status for different breast cancer subtypes. These novel sta-
tistical approaches will be applied to data from the NHS to obtain new knowledge about the prognostic values of
AR and potentially lead to better targeted therapies.

Public health relevance
Narrative We propose novel statistical tools to elucidate the clinical signiﬁcance of prognostic factors in breast cancer survival and to summarize the residual survival time after breast cancer recurrence. Through the application of the proposed methods, we expect to gain new knowledge about the progression of heterogeneous breast cancer, which will lead to better targeted therapies for patients and advances in breast cancer survival. While the proposed research focuses on breast cancer research, the proposed statistical methods will have a broad applicability for other chronic diseases.